Super Resolution STED Microscopy at UNC

PROGRAM DESCRIPTION
This request is for funds to purchase a Leica Tau-Stimulated Emission Depletion (Tau-STED) microscope on
the Stellaris 8 platform with 1 depletion line. This instrument will be housed within the Hooker Imaging Center
(HIC) in the Department of Cell Biology and Physiology in the School of Medicine at the University of North
Carolina at Chapel Hill. The HIC provides access to a full range of light and electron optical, image analysis, and
morphometric methods to all research groups within the University of North Carolina at Chapel Hill, including the
School of Medicine, College of Arts and Sciences, and other professional schools on campus. Super-resolution
microscopy is an essential advancement in optical microscopy techniques in biomedical research that has rapidly
matured over the last 5 years. Currently on campus, there is a single microscope capable of true super resultion
microscopy, to serve the over 350 biomedical research laboratories on campus, and this scope is more than
five years old, and cannot perform super resolution in 3 dimensions, in level cell mode, or at distances > 2 µm
from the coverslip. Recent dramatic improvements provided by the commercially available Leica Tau-STED
microscopy bring higher resolution in all three dimensions, increased sensitivity, and increased suitability for live
cell imaging by exploiting changes in fluorescence lifetime following stimulated emission depletion. Furthermore,
the commercially available 775 depletion line allows facile and gentle gated two color super-resolution imaging,
such that it can be easily deployed in a core environment such as the HIC and accessible to the variety of
research projects and labs on campus. The need for this instrument is demonstrated throughout the application
with several diverse NIH supported projects in fields including; Neurobiology, Cell Biology, Cardiac Biology
Developmental Biology, cytoskeletal biology, basic and disease-oriented protein trafficking biology, RNA and
DNA biology. The abilities provided by Tau-STED will transform our fundamental understanding of the biology
of these many arenas. Since the HIC began serving the imaging community of UNC 14 years ago, it has become
an integral part of the medical research community currently participates in research projects with more than 100
PHS funded groups within the medical area, as well as in PHS supported projects with investigators in other
departments and at neighboring institutions. The steering committee of the HIC, and the directors of non-
overlapping imaging cores on campus together deem that acquisition of a Tau-STED system as an essential
addition to the repertoire of instrumentation available to PHS funded users at the University, and that the HIC is
the optimal core to house the scope for reasons described throughout the proposal.

Public health relevance
PROJECT NARRATIVE Super-resolution microscopy is a critical approach for understanding the fundamental biology of human health and disease. The ability to image individual proteins in fixed and living tissues and cells, including individual synaptic vesicles at the synapse, individual proteins in cardiomyocytes and dendritic spines, t-loops in DNA, cytoskeletal components in the migrating cells, and organelles transforms our understanding of the fundamental building blocks of life. Here we are requesting a Stimulated Emission Depletion Microscope; this fundamental tool will allow practical application of super-resolution microscopy to the largest number of NIH funded research questions.